Building an atlas of B cell mediated protective immunity to alphaviruses

Abstract
This proposal outlines a five-year career development program for Dr. Saravanan Raju M.D., Ph.D. with the
goal of preparing him for an independent research career as an academic physician-scientist. Dr. Raju
completed his M.D. and Ph.D. in Immunology at Washington University in St. Louis and his medical residency
in Clinical Pathology at Barnes-Jewish Hospital/Washington University. With the goal of dissecting the basis of
broad and durable immunity to pathogens, Dr. Raju sought the mentorship of Dr. Michael Diamond, who is a
Professor of Medicine and Co-Director of the Center for Vaccines and Immunity to Microbial Pathogens. Dr.
Diamond is an expert in the field of viral immunology and has previously served as a mentor to physician-
scientists who have transitioned to independent positions in academic medicine. Washington University
provides an outstanding environment for Dr. Raju to develop his independent research career. First, Dr. Raju’s
Advisory Committee comprised of Drs. Ellebedy, Fremont, Amarasinghe, and Murphy has diverse and
extensive scientific expertise relevant to all aspects of this proposal and highly successful track records as
scientific mentors. Second, Dr. Raju will acquire additional scientific, grant-writing, and laboratory management
skills through resources available within the School of Medicine and Office of Postdoctoral Affairs. Third, the
research infrastructure within the Diamond laboratory and on-site core facilities will enable Dr. Raju to
efficiently perform the scientific aims described in this proposal. The goal of the proposed research is to study
the basis by which cross-reactive B cells are induced to arthritogenic alphaviruses in mice. As the genus of
alphaviruses includes several related but antigenically distinct species with established epidemic potential
(e.g., Chikungunya virus and Mayaro virus), knowledge gained from this proposal may inform the development
of pan-alphavirus vaccines. Dr. Raju will engage in formal coursework, workshop attendance, and mentored
practical training in both B cell repertoire analysis and structure determination by cryo-electron microscopy to
accomplish the aims in the proposal. Upon completion, the studies outlined in this proposal will yield insight
into germinal center dynamics in a relevant infection model that can be expanded to other virus families and
serves as a launching point for Dr. Raju’s independent research career.

Public health relevance
PROJECT NARRATIVE Alphaviruses are a genus of RNA viruses with established epidemic potential and limited countermeasures. The design of a pan-alphavirus vaccine may be informed by a mechanistic understanding of how diversity within the B cell repertoire is achieved. In this proposal, mouse models of alphavirus infection will be used to investigate how the germinal center promotes cross-reactive B cell responses and heterologous immunity.